Kansas Department of Agriculture Laboratory's Implementation of a Laboratory Flexible Funding Model

Project Summary
The Kansas Department of Agriculture Laboratory aims to help create a national, fully
integrated food safety system by expanding our testing capabilities in both Microbiology
and Chemistry as well as increase sample throughput in both human and animal product
testing. The Laboratory serves as the primary servicing lab for the Food Safety and
Lodging (FS&L) and Dairy and Feed Safety (DFS) programs. Continued laboratory
accreditation to ISO/IEC 17025:2017 will allow for a complete quality system to ensure
defensible analytical results are put forth. The accreditation attests to the competency
and technical capabilities of a laboratory to perform certain tasks and supports
traceability of data generated. The collaboration between the regulatory programs and
the laboratory will play an integral role in achieving an integrated national food safety
system.

Public health relevance
Project Narrative By participating in this cooperative agreement, the Kansas Department of Agriculture Laboratory (KDAL) aims to successfully expand the testing capabilities in both Microbiology and Chemistry as well as increase sample throughput in human and animal product testing. Additionally, KDAL will continue with their existing quality system consistent with the principles and requirements of ISO/IEC 17025:2017. The standard will attest to KDAL’s competency and technical capabilities to perform tasks and support traceability of data generated. This cooperative agreement will allow for the enhancement of both human and animal food product surveillance. Moreover, it will strengthen the relationship between the laboratory and the regulatory programs. By expanding the existing surveillance program KDA aims to ensure a safer food supply for Kansas.